Structural and Functional Studies of the Uterine Lymphatics

PROGRAM SUMMARY
The uterus is a highly-fluid dynamic organ that experiences significant structural and physiological changes
throughout the estrus cycles, embryo implantation, pregnancy, and post-delivery. We aim to advance our
understanding of the development, structure, and function of uterine lymphatics, focusing on their pivotal roles
in fluid regulation and immune support during both pregnant and non-pregnant states. The project sets out to
trace the postnatal development of lymphatics in mouse uterus, documenting significant physiological
adaptations that occur during pregnancy. Of particular interest is the emergence of "lymphatic sphincters,"
unique structures we hypothesized to manage increased fluid volumes that are critical for fetal development and
maternal health. By exploring how these lymphatics adapt and remodel during pregnancy, we aim to illuminate
their crucial role in maintaining uterine health. Furthermore, the study will investigate how alterations in lymphatic
function might affect the placement and spacing of embryo implantation sites, potentially impacting fetal-maternal
interactions and influencing overall gestational outcomes. Through a variety of experimental approaches,
including the surgical obstruction of lymphatic drainage, we will analyze changes in fluid dynamics and vascular
remodeling across different reproductive states - from the various phases of the estrous cycle in non-pregnant
conditions to dynamic shifts during pregnancy. By providing vital insights into the complex roles of uterine
lymphatics in reproductive health, our research program seeks to fill significant gaps in our current understanding
and pave the way for innovative treatments and strategies for managing pregnancy-related complications. The
outcomes of our work could lead to groundbreaking advancements in gynecological and reproductive medicine,
transforming approaches to enhancing fertility and managing reproductive health disorders. Through detailed
study and innovative methodologies, our proposed study will help to establish a foundation for future clinical
applications and therapeutic strategies, potentially transforming the landscape of women's health.

Public health relevance
PROJECT NARRATIVE The lymphatic system plays a vital role in regulating fluid balance and facilitating immune functions. The uterus, an organ that is exceptionally active in managing tissue fluid and immune reactions, experiences substantial transformations throughout the estrus cycles, conception, embryo implantation, pregnancy progression, and after birth. Our research focuses on examining the growth of uterine lymphatics and their functions in maintaining uterine tissue fluid balance and immune control during both pregnant and non-pregnant states.